ANATOMICAL SUBSTRATES OF COMPLEX BEHAVIOR

The specific aims of this program of research are to elucidate the relationship between human neural systems and memory, vision, emotion, language, and reasoning, and to maintain and expand a Cognitive Neuroscience Patient Registry.